ROLE OF GENE EXPRESSION IN THE CONTROL OF METABOLISM

In biological systems, most processes are under the control of a variety of regulatory mechanisms. For example, the glyoxylate bypass of Escherichia coli is controlled by regulation of the expression of the glyoxylate bypass operon, by the phosphorylation of isocitrate dehydrogenase (IDH) and by allosteric mechanisms. Our long term goal is to characterize the functioning and coordination of these regulatory mechanisms. This proposal focuses on the regulation of expression of the glyoxylate bypass operon and the mechanism(s) responsible for differential expression of its products. The glyoxylate bypass operon encodes the regulatory and metabolic enzymes of the glyoxylate bypass. This bypass is catalyzed by isocitrate lyase (aceA) and malate synthase (aceB) and is regulated by IDH kinase/phosphatase (aceK). The operon is fully induced only during growth on acetate and is repressed if any preferred carbon source is simultaneously present. A goal of this project is to determine the mechanism(s) by which the expression of this operon is controlled. Under this proposal, we will focus primarily on the products of two genes which may encode repressor proteins, iclR and fadR. Although aceA is immediately upstream of aceK, the cellular level of isocitrate lyase is 100 to 1,000 fold greater than that of IDH kinase/phosphatase. One of the goals of this proposal is to identify the mechanism(s) which is responsible for this downshift in expression. Our working model proposes that the downshift in expression results from inefficient translational initiation of aceK, possibly as a result of mRNA secondary structure. Premature transcriptional termination and/or instability of the aceK region of the mRNA also appear to contribute to this downshift in expression and may be secondary consequences of inefficient translational initiation. A variety of approaches will be used to test this and other models which are described in the proposal.